Promoting Real World Implementation of an Evidence-Based Weight Management Intervention in Primary Care

ABSTRACT
Obesity is a major health problem in the United States and associated with increased risk of diabetes. There is
a great need for interventions that can assist with long-term maintenance of healthy body weight and be
sustainably integrated into existing health care teams. We have developed and tested an innovative weight
loss maintenance intervention – Maintaining Activity and Nutrition through Technology-Assisted Innovation in
Primary Care (MAINTAIN-pc) – delivered through the electronic health record (EHR) to help patients maintain
recent intentional weight loss and successful lifestyle strategies. We have conducted and published results
from a randomized clinical trial of MAINTAIN-pc at the University of Pittsburgh and found that participants who
received EHR tracking tools and personalized coaching had significantly lower weight regain at 24 months
(primary outcome) than participants who received EHR tracking tools alone. MAINTAIN-pc leveraged
commonly available health information technology (HIT) tools to track participant progress and support patients
and their providers in ongoing efforts to maintain weight loss. Despite the success of MAINTAIN-pc, two key
questions about the practicality and sustainability of this intervention remain unanswered: (i) whether
the HIT could be adapted at other sites and (ii) whether coaching could be delivered leveraging
existing staff resources rather than interventionists supported by a research grant. We propose a
pragmatic clinical trial to test the implementation and impact of the MAINTAIN-pc protocol in routine healthcare
settings: MAINTAIN PRIME (Promoting Real (World) IMplEmentation). MAINTAIN PRIME will be conducted in
14 primary care practices affiliated with the University of Utah and will capitalize on further advances in HIT
(e.g., dashboards to track patient populations) and team-based care models to deliver the intervention with
minimal support from research staff. MAINTAIN PRIME will measure costs to inform future sustainability, and it
will study workflow and individual, clinical, and organizational attributes to determine facilitators and barriers to
successful implementation. Our proposed project will include three phases: 1) pre-implementation, in which we
will do collaborative implementation design with clinic and IT teams and vanguard implementation mapping; 2)
implementation, in which we will conduct a pragmatic clinical trial with weight change at 24 months as the
primary outcome; and 3) post-implementation, in which we will evaluate the success of MAINTAIN PRIME,
including barriers, facilitators, and costs that will inform future sustainability and be summarized in a “toolkit” to
foster dissemination. By focusing on weight maintenance and relapse prevention, increased use of existing
staff, and integration with HIT systems and tools, we will fill a crucial gap in the long-term treatment of obesity
as a chronic medical condition.

Public health relevance
Project Narrative Many people struggle not only to lose weight through changes in diet and physical activity, but also to maintain weight loss once they have achieved it. In a previous study, our team designed and deployed a weight maintenance intervention that was delivered through the patient portal of an electronic health record (EHR) and found that patients who tracked their weight, diet, and physical activity and also received coaching had better success with maintaining recent intentional weight loss than patients who tracked but did not receive coaching. We propose to repeat the intervention in a new health care system and train routine health care staff (e.g., medical assistants and nurses) to be coaches, a more sustainable model that will allow ongoing intervention delivery after the proposed study ends.